IGF::OT::IGF GWAS HumanOmni2.5 Plus Exome for NIDCR (Diatchenko) FY 2014 CAN 8469539

The Center for Inherited Disease Research (CIDR) is a centralized facility established to provide genotyping and statistical genetics services for investigators seeking to identify genes that contribute to human disease.